Research Core

PROJECT SUMMARY / ABSTRACT
The Next-Generation Clinical Research and Data Science Core will be jointly led by Drs. Simonyan,
Nagarajan and Barkmeier-Kraemer. The Core will monitor clinical and research activities of all Center sites,
including Massachusetts Eye and Ear Infirmary (MEEI), Massachusetts General Hospital (MGH), University of
Utah (UofU), and University of California San Francisco (UCSF). The Core will be responsible for the
development of comprehensive clinical and imaging data repositories of patients with laryngeal dystonia and
voice tremor and the use of these data for the development and testing of machine-learning algorithms for
differential diagnosis of these disorders and the assessment of treatment outcomes. The Next-Generation
Clinical Research and Data Science Core will pursue the following two specific aims: (1) Comprehensive
clinical phenotyping; (2) Research data repository, and (3) Predictive data analytics. The Core's significance is
in developing and implementation of standardized data collection and analytical tools for their availability to all
Projects and associated investigators. In addition, data analytics based on common data across different
Projects and Center sites will facilitate the development of unified diagnostic and treatment biomarkers for
each of these disorders.

Public health relevance
PROJECT NARRATIVE The Next-Generation Clinical Research and Data Science Core will provide a centralized data repository for all clinical and research data collected during the proposed studies of the Center. The Core will also provide the analytical support and develop advanced machine-learning algorithms for predictive assessment models of laryngeal dystonia and voice tremor. As such, the Core will serve and support all Center sites and projects for data acquisition, sharing, and analysis.